Development Therapeutics Branch Clinical Trials

We focus on drugs targeting the genome, especially novel topoisomerase inhibitors as single agents and in combination with DNA repair and immune checkpoint inhibitors. One of our topoisomerase I (TOP1) inhibitors, LMP400 (Indotecan) finished Phase 1 clinical trials. Another (LMP776, Indimitecan) is finishing phase 1 and LMP744 is in phase 1. We have clinical trials with tumor-targeted TOP1 inhibitors (Onivyde, CRLX101, PLX-038 and PEN-866), and clinical trials with combination of TOP1 inhibitors with ataxia-telangiectasia and rad3-related (ATR), poly(ADPribose)polymerase (PARP1/2) and immune checkpoint inhibitors. Our ongoing clinical trials include: Actively recruiting: 13C0131: A Pilot Study of Inpatient Hospice with Procurement of Tissue on Expiration in Thoracic Malignancies; 15C0150: A Phase I/II Trial of Topotecan with VX-970 (M6620), an ATR Kinase Inhibitor in Small Cell Cancers; 16C0107: A Phase I/II Trial of CRLX101, a Nanoparticle Camptothecin with Olaparib in Patients with Relapsed/Refractory Small Cell Lung, Bladder and Prostate Cancers; 17C0117: A Phase 1/2a, Open-Label, Multicenter Study to Assess the Safety, Tolerability, Pharmacokinetics, Pharmacodynamics, and Preliminary Anti-Tumor Activity of PEN-866 in Advanced Solid Malignancies; 18C0110: Safety Run-In and Phase II Trial of M7824 and Topotecan or Temozolomide in Relapsed Small Cell Cancers; 20C0009: Randomized Phase II Trial of Topotecan Plus M6620 (VX-970) vs. Topotecan Alone in Patients with Relapsed Small-Cell Lung Cancer; 20C0013: Phase I/II trial of PLX038 (PEGylated SN38) and Rucaparib in Solid tumors and Small Cell Cancers;17C0012: Ph I MM-398 plus Veliparib.